Administration and Enrichment

ABSTRACT – ADMINISTRATION & ENRICHMENT CORE (A)
The goal of the UW Center for Translational Muscle Research (CTMR) will continue to be a centralizing force
that enhances and accelerates research productivity, through critical services, resources and programs and
training to current and new investigators that are our Center members and affiliates. The CTMR promotes
cooperative interactions and recruitment of new clinicians and academic researchers, and enables acceleration,
effectiveness, and efficiency of new and ongoing research to ultimately translate these efforts into better and
new therapies for muscle diseases. In addition to CTMR resources and programs, this is accomplished by
facilitating important resources and expertise in other Centers and Institutes at the UW and the Seattle region.
The Administrative Core (A) coordinates all the necessary leadership, organizational and supervisory activities
of the CTMR. Importantly, the Administrative Core and all three Resources Cores are in close proximity (in three
adjacent and connected Research buildings) on the South Lake Union campus of the UW Medical School.
The Specific Aims of Core A are to: Aim 1: Provide Effective Leadership, Management and Evaluation of
the Center; Aim 2: Recruit New Members and Promote Collaborations; Aim 3: Administer the Pilot Awards
Program; Aim 4: Provide Communication and Promotion of the CTMR; and Aim 5: provide Outreach and
Mentoring Activities. The Administrative Core is essential to accomplish the overall goals of the Center and the
Seattle area research community to create a `Google Earth' equivalent of muscle research, giving researchers
the ability to study muscle at all scales, from the atomic level where disease begins to the tissue level where
patients are most impacted. The success of the Pilot Awards program has resulted in additional resources that
will be provided by various UW entities in the renewal period. The biomedical research community in the Seattle
area is broad and diverse and covers many disciplines and fields. The integration of these efforts by being
inclusive and progressive is one of the great strengths of Center that is orchestrated through this Core. Multiple
Center efforts go beyond the Seattle area, to the Pacific Northwest region and across the US and western Europe
through collaborations, seminars and skills training. Providing a unified strong environment and voice for the
muscle community, that spans research, the clinic and industry will continue to serve individual and collective
research goals. Support from the P30 is crucial to maintain and grow the strength and vitality of our muscle
research community.